HOPE in Action: A Clinical Trial of HIV-to-HIV Liver Transplantation

End-stage liver disease is common in HIV-infected (HIV+) individuals due to co-infection with hepatitis C virus
(HCV), hepatitis B virus (HBV), and alcoholic and non-alcoholic fatty liver disease (NAFLD). Liver transplant
(LT) in HIV+ individuals provides a clear survival benefit and outcomes will improve further with direct-acting
antivirals for HCV. There is already a severe organ shortage, with long waiting times, and a higher waitlist
mortality for HIV+ individuals in particular, and the need for LT in HIV+ individuals is expected to grow.
Organs from HIV+ deceased donors (HIV D+) are a unique resource for HIV+ transplant candidates. By
expanding the donor pool, use of organs from HIV D+ could have a significant public health impact and
decrease wait times for all individuals on the waitlist. This motivated the Congressional HOPE (HIV Organ
Policy Equity) Act which now allows HIV D+ transplants for HIV+ recipients (R+) under research protocols.
Potential risks of HIV D+/R+ transplants include complications related to donor-to-recipient HIV
superinfection (HIV-SI), increased organ rejection rates, and accelerated liver fibrosis and/or steatosis after
transplant due to viral hepatitis or metabolic liver disease. Experience with HIV D+ LT is extremely limited with
only 2 international cases reported and 5 cases in the US performed by our group within a HOPE pilot study.
In order to determine if HIV D+ liver transplantation is safe and effective, a prospective multicenter trial is
needed. The proposed HOPE in Action Liver Trial will compare outcomes between HIV+ recipients of HIV+
versus HIV- donor livers, enrolling 40 individuals in each group over 3 years at 16 transplant centers. Aim 1 will
compare difference in time to major transplant-related and HIV-related complications between the two arms.
Aim 2 will compare the incidence of liver disease including HCV- and HBV-related fibrosis and liver steatosis.
Mechanistic studies in Aim 3 will characterize HIV-SI in blood and in Aim 4 will characterize both the
composition and changes in size of long-lived HIV reservoirs in blood, lymph nodes, and liver longitudinally. A
comprehensive digital pathologic repository and a tissue biorepository will be created.
We have planned and designed the trial with NIAID-sponsored project team (R34AI23023) and we have
assembled a team of experts in Transplant Surgery, HIV/Infectious Diseases, Hepatology, Epidemiology,
Biostatistics, Pathology, and Virology. The trial will benefit from existing studies and infrastructure established
by our group, including a study of HIV D+ nationally in collaboration with the Organ Procurement and
Transplantation Network (R01AI120938) and a Multicenter HOPE in Action Kidney Trial (U01AI134591).
In summary, HOPE in Action: A clinical trial of HIV-to-HIV deceased donor liver transplantation will
determine whether the use of HIV D+ for LT is safe and effective. In addition, the trial will impact not only the
field of organ transplantation, but will also provide new insight into mechanisms of HIV-related liver disease,
HIV superinfection, and will directly inform HIV cure research efforts.

Public health relevance
Public Health Relevance The HIV Organ Policy Equity (HOPE) Act permits research on the use of HIV-infected (HIV+) donors for transplantation into HIV+ individuals in order to alleviate the organ shortage and save the lives of those on the organ transplant waitlist. In the proposed trial, we will study key outcomes in HIV+ recipients of HIV+ donor livers including survival, liver function, organ rejection, changes in the HIV virus and immune system, and development of resistance to HIV drugs. These studies will determine the safety of HIV+ donor liver transplant and will contribute to other areas of research including HIV-related liver disease and HIV cure.